Development and Evaluation of Rosette Array Technology for HumanNeurodevelopmental Toxicity Screening

Project Summary
Pre-clinical and pre-field toxicology testing of new drugs and chemicals does not routinely include direct
assessment of human developmental neurotoxicity (DNT). Current standards for DNT testing require use of
animal models with limited throughput and significant differences from human central nervous system (CNS)
development. As such, many chemical products have required post-approval (EPA/FDA) restrictions or
cancellations due to human DNT. Such limitations of the current regulatory DNT testing paradigm have
prompted increased interest in quantitative high-throughput screening (qHTS) using human pluripotent stem
cell (hPSC)-based approaches. Here, we propose to use Rosette Array (RA) technology to develop an hPSC-
derived qHTS platform (i.e., qHTS-RAs) for effective and efficient DNT testing. Rosette Array technology
standardizes in vitro derivation of human neural rosettes tissues that are mimetic of transverse slices of the
human neural tube, the anlage of all CNS tissue. Although neural rosettes are not an exact recapitulation of in
vivo primary neurulation, they exhibit the same cell phenotypes, tissue cytoarchitecture, and are derived using
morphogenetic signaling pathways endogenous to the in vivo neural tube formation process. Rosette arrays
are the first in vitro technology to enable spatial and temporal control of neural rosette emergence in a
microarray format. This enables rapid assessment via microscope image analysis. This high-yield,
standardized generation of in vitro neural tube analogs enables the repeatability necessary to feasibly
incorporate hPSC-based CNS morphogenic readouts into quantitative high-throughput toxicology screening.
Thus, we hypothesize that the qHTS-RA platform could increase throughput and accuracy of human DNT risk
assessment, allowing consolidation and scale-up of commercial DNT screening. Phase 1 Aims will validate the
broad applicability of the qHTS-RA platform, confirming compatibility with human induced pluripotent stem cell
(hiPSC) lines and establishing methods for automated image acquisition and batch analysis. Phase 2 Aims to
validate assay fitness with a 100 compound DNT reference library screen, in which automated AI image
analysis is utilized to further increase accuracy and maximize throughput. If successful, the resulting qHTS-RA
platform could replace multiple current DNT assays and increase confidence in toxicological readouts relevant
to outcomes unique to human physiology. Thus, the work proposed here could have a transformative effect on
DNT research, regulatory efforts to prevent DNT exposure, and future translatability of hPSC-based organoid
models for broad study of human development.

Public health relevance
Project Narrative Toxicology screening of commercial chemicals is typically conducted using an assay battery heavily reliant on animal models, which diverge from humans especially in aspects of central nervous system development. Here, we propose to develop and evaluate a quantitative, human pluripotent stem cell-derived, high-throughput screening platform that standardizes neural rosette morphogenesis, modeling early CNS development, for developmental neurotoxicity (DNT) applications. If validated, the novel screening platform would streamline DNT assay batteries and increase the accuracy of chemical safety assessments.